Core B - Bioanalytical, Mass Spectroscopy, Imaging and Histology Core

CORE B – BIOANALYTICAL, MASS SPECTROSCOPY, IMAGING AND HISTOLOGY CORE
PROJECT SUMMARY/ABSTRACT
The Cardiorenal and Metabolic Diseases Research Center (CMDRC) was established to enhance research
infrastructure and provide mentoring to increase the ability of COBRE investigators to successfully compete for
independent NIH funding. The Bioanalytical, Mass Spectroscopy, Imaging and Histology Core B was
established as a resource for the CMDRC during Phase I, and this core has had a transformative effect on
COBRE junior investigators, Pilot Grant investigators, and investigators from local Historically Black Colleges
and Universities (HBCUs). During Phase I of COBRE support, Core B established services critical to
cardiorenal and metabolic diseases researchers in addition to numerous investigators who collaborate with
members of the CMDRC. Core B provides access to technologies and services that would otherwise not be
available in Mississippi. This includes consolidated, highly specialized services and state-of-the-art resources
staffed by professional personnel who are not only capable of performing a variety of essential research
services, but are also able to provide training and assist in the development of new research methods to meet
the changing needs of COBRE investigators. Core B has multiple components including the Bioanalytical/Mass
Spec Sub-Cores that provide centralized radioimmunoassay (RIA), ELISA, HPLC, LC/Mass spectroscopy,
proteomics, lipidomics and other biochemical/chemistry analyses, and the Histology/Imaging Sub-Cores that
provide access to state-of–the-art imaging equipment as well as histology, immunohistochemistry, and other
key services. Faculty from over 15 different basic science and clinical departments at UMMC in addition to
researchers from other institutions including Jackson State University, a HBCU, used services and resources
provided by Core B during Phase I of COBRE support. Resources and services provided by Core B were
substantially expanded during Phase I and this was supported by the addition of new state-of-the-art
equipment to each Sub-Core. Usage of Core B by investigators facilitated the generation of >250 publications
and provided direct support for the receipt of many extramural funded grants from NIH and other non-profit
funding agencies. Establishment of Sub-Cores as Recharge Centers initiated our business plan for
sustainability and Core B will continue to build upon our success so that we can provide continuous support for
existing infrastructure, resources and services, and expand Core offerings to meet the needs of cardiorenal
and metabolic disease researchers at UMMC.

Public health relevance
CORE B – BIOANALYTICAL, MASS SPECTROSCOPY, IMAGING AND HISTOLOGY CORE PROJECT NARRATIVE The Bioanalytical, Mass Spectroscopy, Imaging and Histology Core B provides access to technologies and services that would otherwise not be available in Mississippi. This includes the Bioanalytical/Mass Spec Sub- Cores that provide centralized radioimmunoassay (RIA), ELISA, HPLC, LC/Mass spectroscopy, proteomics, lipidomics and other biochemical/chemistry analyses and the Histology and Imaging Sub-Cores that provide access to state-of–the-art imaging equipment as well as histology, immunohistochemistry, in-situ hybridization and other key services. This Core is staffed by professional personnel who are not only capable of performing a variety of essential research services, but are also able to provide training and assist in the development of new research methods to meet the changing needs of COBRE investigators.